Optimizing Cell Therapy to Counter Adaptive Resistance Mechanisms in Prostate Cancer

Prostate cancer is the most frequently diagnosed cancer for men in the United States and VA cancer patients
and is the second largest cause of cancer-related death in men. Advanced prostate cancer, which develops in
10-20% of all prostate cancer patients, is typically bone-metastatic and resistant to androgen deprivation therapy.
The relative 5-year survival rate for patients with advanced prostate cancer is 28% and the median overall
survival ranges between 9-13 months. Therefore, novel treatment options are needed for patients with advanced
prostate cancer. Adoptive transfer of T lymphocytes engineered to express chimeric antigen receptors (CARs)
is a novel therapeutic modality that has generated unprecedented responses in patients with highly refractory
CD19' B cell leukemia and lymphoma and BCMA' multiple myeloma and holds promise as a potential treatment
for prostate cancer. In a recent phase I trial hailed as a clinical milestone in prostate cancer, 13 patients were
treated with autologous PSMA-specific CAR T cells armored with a dominant-negative TGF-β receptor. Four
patients achieved a >/=30% reduction in PSA and the failure of the CAR T cell therapy was accompanied by an
adaptive response in the tumor microenvironment (TME) that led to upregulation of multiple localized inhibitory
molecules. The central hypothesis of this proposal is that adaptive resistance utilizes multiple mechanisms to
escape surveillance and attack from the immune system; therefore, immune cells engineered with multipronged
approaches to target the tumor, the TME, and overcome adaptive resistance mechanisms will prevent CART
cell failure and tumor escape. In prior studies, CAR T cell therapies targeting glycoforms of mucin1 and
fibronectin post-translationally modified with the Tn antigen, a truncated O-glycan, demonstrated tumor-specific
activity against prostate cancer in xenograft models and a reduction in tumor metastases. These studies
identified loss of interferon-gamma signaling as an adaptive resistance mechanism that desensitizes tumor cells
to CART cell-mediated cytotoxicity and agonists of TLR signaling that induced an interferon-like gene signature
synergized with CAR T cells to overcome this resistance mechanism. The rationale for this research is that
identification of counter resistance mechanisms that maintain CAR T cell activity in the context of adaptive
resistance by prostate tumors. The central hypothesis of this proposal will be tested by pursuing three
independent specific aims: 1) to design dual-targeting CAR T cells and strategies to modulate target antigen
expression to prevent tumor escape; 2) to identify mechanisms of CART cell and TLR agonist synergy in prostate
tumors deficient in interferon-gamma signaling; 3) to enhance CART cell resistance to immune checkpoint and
immunosuppressive cytokines. This research will enhance the depth of understanding on the mechanisms of
tumor escape through adaptive resistance as well as the breadth of immunoengineering strategies and
therapeutic options in the pipeline of potential prostate cancer treatments.
Project Summary/Abstract

Public health relevance
Prostate cancer accounts for nearly one-third of all cancer diagnoses amongst men in the VA patient population, and a percentage of prostate cancer patients will develop bone metastatic cancers, which remain incurable. Current standard-of-care treatment options for bone-metastatic prostate cancer improve overall survival by a modest four months, highlighting a need for more efficacious therapies. Adoptive transfer of engineered immune cells has led to decade-long remissions in adult and pediatric patients with B cell leukemia and a phase I clinical trial of engineered immune cells in patients with metastatic castrate-resistant prostate cancer (mCRPC) demonstrated feasibility and promise. In the proposed research, we aim to develop engineered immune cells capable of overcoming adaptive resistance mechanisms of prostate cancer, including targeting multiple antigens simultaneously, negating immunosuppressive signaling, and synergizing orthogonal mechanisms of immune engagement and cytolysis to improve treatment options for veterans with prostate cancer.